Plasma Sterilization Device Compatible with Long-Lumen Scopes

Abstract
Ethylene Oxide (EtO) sterilization is the most common method that effectively sterilizes many types of medical
equipment, especially those that are heat-sensitive, made from certain polymers, or with long lumens. However,
EtO systems suffer from the long sterilization time, high cost, the high toxicity of EtO, and negative environmental
impacts. As a promising alternative, hydrogen peroxide gas plasma (HPGP) sterilization eliminates most of the
above disadvantages, but the HPGP cannot sterilize narrow or long lumens of medical scopes due to the
suppressed gas diffusion deep inside the lumen, limiting its potential to completely replace EtO. In addition,
HPGP sterilization may fail if a thorough drying and careful loading of the equipment were not performed.
To develop an equivalent or improved solution to EtO while retaining the advantages of HPGP, Advanced
Cooling Technologies, Inc. (ACT), in collaboration with Rutgers University (RU), proposes an ozone plasma
sterilization system with plasma-in-lumen technology. The system uses air to generate plasma containing strong
sterilizing agents such as ozone (O3) and hydroxyl radicals at near-atmospheric pressure. The plasma is
generated inside a sterilization pouch that is made from reusable and flexible sheet plasma generators to reduce
sterilization time and system weight. Additionally, the system has an innovative thin-tubing plasma generator
that can be directly inserted into the long lumens of surgical scopes to supply ozone, fundamentally eliminating
the lumen length limits of the current HPGP systems. The system will accommodate multiple pouches at once
to increase sterilization throughput. Further, the ozone sterilization can operate without thorough drying, and the
insulation layer on the sheet plasma generator can eliminate failure due to improper loading.

Public health relevance
Project Narrative Improved plasma-based sterilization device without lumen length limit: The development of the proposed ozone plasma sterilization system is expected to replace the Ethylene Oxide (EtO) sterilization systems. In the proposed technology, a thin-tubing plasma generator can transport ozone, a strong sterilant, directly into the long lumens of the scopes that are considered hard to reach for conventional plasma Sterilization technologies. As a result, medical scopes with lumens at any length can be quickly sterilized without the disadvantages of EtO and effectively reduce the risk of infection during improper sterilization.